AirPen: A Wearable Sampler for Airborne Hazards in support of Disaster Response Research

Abstract
Both the global mean temperature and the frequency of climate-related disaster events are on the rise. Climate
disasters can expose humans to myriad environmental hazards. For example, wildfires emit massive quantities
of particulate matter (PM) and volatile organic compounds (VOCs) into ambient air. Prolonged periods of drought
contribute to dust storms that can expose people to high concentrations of airborne soil containing transition
metals, pesticides, herbicides, and microbiological hazards. Additionally, storm damage to industrial facilities
and containers can result in stored VOCs being released. Despite the wide range of air pollutants to which
humans can be exposed in the wake of climate-related disasters and the increasing likelihood of these disasters,
the technology toolkit for assessing outdoor levels of, indoor levels of, and personal exposures to multiple air
pollutants rapidly, accurately, and on a large scale during and after disasters is limited.
The objective of this Phase I SBIR proposal is to commercialize a versatile, reliable, and scalable device for
characterizing exposures to PM and VOC air pollution in the wake of disaster events. This small, battery-
powered, and virtually-silent device—called the AirPen—can be worn by a person or deployed as a stationary
monitor. The AirPen samples PM onto a filter and VOCs onto a sorbent while simultaneously logging real-time
sensor data to indicate how PM, VOCs, CO2, noise, and light levels vary over time and space. The physical
samples collected by the AirPen can be used to determine exact time-averaged pollutant concentrations and
species-specific pollutant composition (e.g., to identify the presence of toxic metals, such as lead, in PM and
carcinogens, such as formaldehyde or benzene, in gas samples). By combining spatiotemporal sensor data
with time-integrated pollutant sampling, the AirPen can serve as a powerful tool for assessing human exposure
and guiding efforts to mitigate disaster-related health effects.
The first aim of this project is to collaborate with disaster response researchers to measure ambient PM and
VOC pollution, using research prototype AirPens, in real-world demonstration projects involving wildland fires,
storms, and waste disposal sites—with the end goal of gaining feedback from these collaborators on how to
improve the usability, reliability, and scalability of the commercialized version of the AirPen. The second aim is
to design, prototype, test, and validate the performance of improved air pump manifold and active flow control
systems that will reduce the AirPen bill-of-materials, assembly, and service costs. The third aim of this project
is to incorporate findings from the first two aims into a commercially-viable AirPen design that meets the needs
of disaster response researchers, can collect gas samples onto a variety of different sorbent media (depending
on the application), can support wireless data transmission from remote monitoring sites, and is more
affordable to manufacture and assemble than the current research prototype.

Public health relevance
Project Narrative Climate-related disasters—such as wildfires, dust storms, extreme-weather events, and floods—are occurring with increasing frequency and can expose the public to harmful air pollution. We will develop a small, quiet, wearable device that can be deployed to estimate exposures to airborne pollutants (such as particulate matter and volatile organic compounds) at many locations and across many people at the same time. Measurements made using this device can (a) tell government agencies and the public how much and what kinds of pollution people have been exposed to during and after a disaster as well as (b) inform efforts to address the health risks faced by the exposed population.